Authentic Community Engagement in Science (ACES)

The Atomic Circus Experience (ACE) Project
Matt Queen & Amanda Obery
Improving student access to quality biochemical and STEM education has been a focus of rural
educational reform for many years. Positive experiences for students prior to middle school are
critical given research showing that students who have an interest in STEM in middle school are
significantly more likely to pursue careers in these fields than those who aren’t interested. As
part of a holistic approach to this issue, the Atomic Circus Experience (ACE) Project builds on
the power of collaborative partnerships and community engagement, shown to be effective
ways in working with rural and Native students. Centering on fifth grade students, the ACE
Project seeks to build knowledge and interest in biomedical and STEM careers throughout
Eastern Montana including rural and tribal communities. To accomplish this goal, the ACE
project will work with local teachers, and biomedical professionals to develop a culturally-
relevant, place-based biomedical and STEM curriculum, ensuring all students can identify and
have role models in these fields. The curriculum will focus on increasing biochemical content
knowledge and career aspirations by engaging students through a problem-based learning
approach based on local phenomena. The curriculum is reinforced using a traveling,
community-customized, multimedia biochemical stage show featuring actors, a full rock band,
and a troupe of interpretive dancers. In addition to the work done with the schools, a community
engagement night will offer a public showing of the show will also feature a research bus open
house and accompanying INBRE-based biomedical researcher. The ACE Project will travel to
six communities in Eastern Montana, impacting approximately 7,200 students over the course of
5 years. Overall, this project is innovative in its multifaceted approach to working with rural and
Native students and calls upon promising, yet under-used, approaches in culturally relevant and
place-based pedagogies, based in the Next Generation Science Standards, in order to make
lasting changes in communities around support for biomedical and STEM fields.

Public health relevance
Project Narrative The Atomic Circus Experience (ACE) Project has the goal of exposing students and the communities of Eastern Montana to STEM and biomedical concepts and careers, helping them recognize and understand the pathways to future biomedical employment. The ACE goal is accomplished through collaborations with local educators, biomedical professionals, and community members to develop a customized multimedia biochemistry stage show, as well as culturally relevant, place-based STEM curriculum. The curriculum engages students with local community members involved in biomedical and STEM work, the show ignites a passion for learning which then paves the way for solving local issues using biochemical and STEM skills and knowledge.